NK cell inflammation resolution circuits in pediatric RSV infection

Project Summary/Abstract
Respiratory syncytial virus (RSV) is the major cause of bronchiolitis and pneumonia in young children and the
leading cause for hospitalization of infants. A subset of RSV-infected children develops severe protracted lung
inflammation that leads to respiratory failure and even death but effective therapies for RSV are lacking. Our
preliminary data for this proposal implicates a role for NK cells in the pathobiology of RSV infection. We have
determined that NK cells are abundant in the airways of RSV-infected children with profound hypoxemia and
that NK cell cytotoxicity is impaired in pediatric RSV. NK cells are pivotal mediators of innate viral immunity and
are also key cellular effectors of inflammation resolution to clear inflamed tissues of virus-infected and
activated cells through immune synapse formation and lytic granule delivery to trigger targeted apoptosis.
Disrupted inflammation resolution can perpetuate tissue damage and chronic inflammation; hence, NK cell
resolution function is critical to prevent protracted lung inflammation. Resolution of inflammation is an active
process mediated in part by specialized pro-resolving mediators (SPMs), a family of endogenous fatty acid-
derived molecules that counter inflammatory signals and accelerate resolution through cell-specific actions. We
recently identified that SPMs mitigate RSV-induced lung inflammation in mice, but whether RSV impacts SPM
resolution pathways in humans remains unknown. In preliminary data for this proposal we identify for the first
time that NK cells in human RSV express receptors for the SPMs resolvin D2, resolvin E1, and lipoxin A4. We
have determined that the SPM lipoxin A4 up-regulates NK cell cytoskeletal proteins to promote lytic granule
trafficking and augment cytotoxicity, distinct from steroids that disrupt NK cell cytoskeletal dynamics and impair
cytotoxicity. This proposal will test our central hypothesis that RSV infection alters airway and circulating NK
cell immunophenotype and disrupts cytoskeletal signaling pathways to impede NK cell resolution functions that
can be restored by exogenous SPMs. To test this hypothesis in pediatric RSV+ ICU patients, we will pursue the
following specific aims: Aim 1: Determine NK cell immunophenotypes and effector functions in pediatric RSV
infection; Aim 2: Define mechanisms for disrupted lytic granule trafficking that governs NK cell cytotoxicity; and
Aim 3: Establish circuits of defective inflammation resolution linked with pediatric RSV infection. This proposal
brings an innovative approach to the study of RSV by leveraging human pediatric biospecimens to determine
a novel NK cell–SPM immunoregulatory axis and utilizes cutting-edge mechanistic immunology techniques to
identify and probe novel targets in RSV. This proposal has relevance to public health as an unprecedented
post-pandemic surge of pediatric RSV infection is currently overwhelming hospitals and pediatric ICUs and
identifying new immune targets for potential therapeutic or preventative strategies is urgently needed.

Public health relevance
Project Narrative Respiratory syncytial virus (RSV) infection can cause severe lung inflammation and life-threatening illness in young children but there are currently no available therapies to treat or prevent RSV. This study focuses on understanding how RSV infection triggers defective natural killer (NK) cell immunity and disrupts inflammation resolution pathways that contribute to lung inflammation and respiratory failure in children. Restoring host- protective NK cell immune pathways with specialized pro-resolving mediator molecules has the potential to lead to novel therapeutic approaches to accelerate the resolution of lung inflammation in RSV infection.